CHARMM Development for Performance, Big-Data Accessibility and Usability

Summary CHARMM (Chemistry at Harvard Macromolecular Mechanics) has been a primary research tool for macromolecular simulation and modeling in biology for nearly three decades. During this period CHARMM development, applications emerging from its use have defined the field of biomolecular computation. This proposal is aimed at ensuring that CHARMM will continue as the development platform for future generations of scientists by addressing components of the software and its attendant support infrastructure that represent bottlenecks in development, performance and maintenance. Specifically, continued refactoring of the code will provide improvements and extensions to underlying computational kernels in CHARMM, which will significantly enhance single processor performance and improve parallel scaling. Additional developments will establish a more extensive and user friendly front end for complex simulation preparation using CHARMM-GUI (http://www.charmm-gui.org) and embracing the emerging big data as drivers of biological simulations approaching cellular level modeling. Emphasis will be given to improving parallelism and accelerated simulations by extending the new and successful DOMDEC kernels for scalable parallel applications, migrating more of CHARMM exceptional functionality to GPU-based accelerators through both DOMDEC and the CHARMM/OpenMM interfaces. Additionally, we will focus on the establishment of a scalable simulation architecture for systems approaching hundreds of millions of particles utilizing both detailed atomic as well as coarse-grained models. The outcome of these efforts will be a program platform that will facilitate continued forefront research in macromolecular simulation and modeling and enable its continued development and maintenance for future generations of researchers.

Public health relevance
Relevance CHARMM (Chemistry at Harvard Macromolecular Mechanics) has been a primary research tool for macromolecular simulation and modeling in biology for nearly three decades, assisting biomedical researchers in theoretical investigations of protein/nucleic acid-ligand interactions, enzyme mechanism, protein/nucleic acid folding, free energy and docking simulations for drug discovery and design, and a large range of other applications in protein, nucleic acid, carbohydrate and membrane modeling. The more than 25,000 citations to CHARMM attest to the pivotal role that this software package and force field has in the biomedical community. The aims of this proposal are to continue to modernize, improve performance, enable the utilization of large data as a key contributor to macromolecular modeling, maintain to a solid pathway for continued development of the CHARMM package to ensure its ongoing availability for biomedical researchers, and establish a more extensive and user friendly front-end for complex simulation preparation using CHARMM-GUI.